Integrated Physiology Training: Molecule to Organism

PROJECT SUMMARY
Over the last twenty years, training in Physiology departments throughout the country has undergone a
transformation that creates a challenge for students seeking an understanding of the discipline at the whole animal
to the cellular and molecular levels. One exception is the Physiology Department of the Medical College of
Wisconsin (MCW), that offers exceptional research training emphasizing the integration of knowledge at all of
these levels, and the relationship of this knowledge to human disease processes. In our current proposal, we will
continue providing this outstanding training in cellular, molecular, and whole animal Physiology for 6 NIH-
supported trainees each year. In addition, we request funds to provide stipends for 6 rising 2nd year medical
students enrolled at MCW to spend 11 weeks during the summer engaged in research in the laboratory of one
of our faculty to enhance recruitment of medical students into biomedical research. Unique aspects of the
proposed PhD training are the multidisciplinary mentoring program and opportunities for translational research
fostered by a highly collaborative basic science and clinical faculty. Graduate students will be recruited nationally
and selected for admission on the basis of undergraduate academic credentials, previous research experience,
and commitment to a career in research. Students must successfully complete the requirements of the first two
years of graduate school before being considered for T32 support. Selection of T32 trainees will be based on
performance in course work, the preliminary examination and in research. Trainees are full-time Ph.D. candidates
in the MCW Graduate School, and will complete a research that includes use of the techniques in molecular,
cellular, tissue, and whole-animal or clinical investigation. Research training is supervised by Physiology faculty
along with co-mentors from other basic science and clinical departments. Trainees will undergo continuous
evaluation by utilizing Individual Development Plans created upon matriculation, which are reviewed and updated
yearly. The major objective is to provide trainees with a broad foundation in interdisciplinary basic science and
translational research through developing critical thinking, integrative reasoning, and technical skills required to
succeed in evolving research careers focused on the prevention of hypertension, stroke, and respiratory diseases.
An innovative feature of the training is the emphasis on addressing the national need to train for the integrated-
systems approaches that represent the future of biomedical research in the post-genomic era. The success of
our program in research is indicated by the 47 first-authored publications from 24 T32 supported graduates over
the past 10 years (Table 5A), and their contribution to 51 manuscripts coauthored with other students or faculty,
indicative of our highly collaborative training program. Another measure of overall success of our program is that
94% of T32 trainees who completed our program over the past 15 years (Table 8A) have continued in a
biomedical field, with 18 obtaining research, teaching, and/or patient care faculty positions and only two trainees
withdrew from the program without obtaining the PhD (average duration of training was 4.96 years).

Public health relevance
PROJECT NARRATIVE Since cardiovascular and respiratory diseases including heart attack, high blood pressure, stroke, asthma, and emphysema are major health problems in the USA and world-wide, it is necessary to train physicians and scientists to improve the care of those afflicted and to learn how to prevent these diseases. Accordingly, we are requesting funds to support six pre-doctoral students each year for the next five years in training that includes broad course work and focused interdisciplinary research that will provide students with an understanding of the fundamental components of the human body (molecules and cells) and how these parts function together in the intact human body. Our students will be prepared to: a) conduct research using novel techniques and methods, and b) teach future generations of physicians and scientists how the human body works in health and disease.